Administrative Core

ABSTRACT
The Administrative Core will provide administrative support to PPG scientists with the goals of coordinating all
components of the program, enhancing interactions between the components of the PPG, optimizing the
efficiency of the operation, establishing internal and external vehicles for communication, and providing
accounting support consistent with federal and institutional policies and procedures. The Administrative Core
will be led by David Schwartz, MD who will coordinate interactions with the Scientific Projects and Research
Cores, institutions (University of Colorado, National Jewish Health, and University of North Carolina), Internal
and External Advisory Committees, and NHLBI. Ivana Yang, PhD will serve as Associate Director of the
Administrative Core and she will assume responsibilities for organizing the Scientific Project (every 2 weeks),
Research Core (every 2 weeks), and Program (monthly) meetings and will also be responsible of the outside
scientific speaker program and the public component of the annual PPG retreat. The Administrative Core will
play a central role to support the organizational structure, and promote and coordinate interdisciplinary
research in PPG. The objectives of the Administrative Core include:
 Support the administrative needs of PPG scientists and provide fiscal management
 Coordinate and integrate internal components of the PPG
 Coordinate and integrate the PPG with external stakeholders
 Provide overall leadership for the PPG